A Novel Pathogenic Pathway for Diabetic Keratopathy

PROJECT SUMMARY / ABSTRACT Diabetic keratopathy is a complication of diabetes and a major cause of vision loss. There are no effective drugs that can prevent or reverse corneal defects related to diabetes. Two independent longitudinal clinical studies have shown robust therapeutic effects of fenofibrate, a specific agonist of Peroxisome Proliferator-Activated Receptor-α (PPARα), on diabetic retinopathy. Our preliminary studies using diabetic human donor corneas and animal models suggest a role of PPARα in maintaining corneal nerve integrity. In our preliminary studies, we have fabricated an innervated 3D in vitro human corneal model that demonstrates basic anatomical and physiological similarities to the corneal tissue in vivo. Using this novel model we began unravelling PPARα’s role in diabetic keratopathy. Significant downregulation of PPARα expression was seen in cells from both T1DM and T2DM human donors, in agreement with decreased PPARα levels as shown in diabetic human corneas. Our in vivo preliminary studies have shown that non-diabetic PPARα knockout (PPARα-/-) mice have decreased densities of the sub-basal nerve fibers and reduced corneal sensitivity, similar to what is seen in diabetic humans. Furthermore, to our surprise, aged, non-diabetic PPARα knockout mice naturally developed more severe corneal ulcerations compared to that in age-matched WT mice. Treatment of diabetic rats with fenofibric acid, an active metabolite of fenofibrate, alleviates corneal nerve degeneration in diabetic rats. As shown by Seahorse analysis, mitochondrial function is impaired in PPARα-/- retina. Based on these preliminary studies, we hypothesize that diabetes-induced down-regulation of PPARα expression plays a key pathological role in diabetic keratopathy and represents a novel drug target. We propose the following studies to address the hypothesis. First, we will induce diabetes in PPARα-/- mice and PPARα transgenic mice over-expressing PPARα in the cornea, to determine if PPARα KO exacerbates while PPARα over-expression alleviates diabetes-induced decreases of corneal nerve density and sensitivity. We will also treat diabetic mice with fenofibrate to determine if activation of PPARα arrests progression of corneal nerve fiber degeneration. Second, we will determine if the neuroprotective effect of PPARα is through attenuation of oxidative stress and inflammation, protection of mitochondrial functions and up-regulation of neurotrophic factors using PPARα-/- mice and PPARα transgenic mice as well as the innervated in vitro 3D human corneal model. Third, to translate the neuroprotective PPARα function into a therapy, we will evaluate therapeutic efficacy of topical application of a proprietary fenofibrate eyedrop on diabetes-induced nerve fiber degeneration. This study has potential to identify a new function of PPARα in the cornea. These studies have potential to establish a novel pathogenic mechanism for diabetic keratopathy and to lead to the development of a novel therapy.

Public health relevance
PROJECT NARRATIVE Approximately 380 million people worldwide are suffering from diabetes mellitus and the majority of them will encounter corneal defects at some point in their life. We propose to investigate the role of a novel mediator, PPARα, in human diabetic keratopathy, both in vitro and in vivo. The proposed studies have potential to identify a new therapeutic target for prevention or treatment of diabetic corneal complications.